Understanding Cardiac C-Looping Using Microscale In Vitro Models

Defects in laterality are observed in more than 1 in 8000 live births and have significant clinical implications.
The embryonic heart starts as a straight cardiac tube along the midline of the embryo, which is subsequently
transformed into a c-shaped heart loop reliably toward the right side of the body. This cardiac c-looping is
considered as the earliest evident event of left-right (LR) asymmetry breaking (also called chirality or
handedness) of a human organ. The inversed lateralization of cardiac looping often leads to severe clinical
outcomes, including dextrocardia, septum defects, double outlet right ventricle, and even death of fetuses and
infants. Accumulating evidence suggests that asymmetric cardiac looping derives from an unknown tissue-
intrinsic mechanism. Recently, we have recapitulated chiral morphogenesis on micropatterned surfaces and in
3D hydrogels and demonstrated that cardiac cells have a definite chirality before asymmetric looping. Protein
kinase C (PKC) activators can reverse both cell chirality and cardiac c looping. Our rationale is that novel cell
chirality based high-throughput platforms, together with a better understanding of molecular mechanisms of
cell chirality, can facilitate the LR symmetry research. We propose to use a combination of micro-fabrication,
hydrogel technology, live-cell imaging, molecular assays, traction force microscopy, high-throughput screening,
ex vivo culture, and genetic mouse models as tools to elucidate the biophysical and biochemical mechanisms.
Our objectives are to determine biomolecular and biomechanical mechanisms of PKC regulated cell chirality
and asymmetric looping and to identify cytoskeletal mechanisms of cell chirality during cardiac c-looping.
SPECIFIC AIM 1: Identify components and signaling pathways that regulate cardiac chirality with high-
throughput screening and validate with ex ovo embryo culture. We will screen inhibitors/activators of PKC
isoforms, their downstream effectors, possible substrates, and a small-molecule kinase library, determine
mechanisms of action, and validate the findings with the whole-embryo ex ovo culture.
SPECIFIC AIM 2: Determine the biomechanical role of cell chirality in multicellular morphogenesis. We
will examine whether chiral mechanical forces are sufficient to induce cardiac c-looping using traction force
microscopy and whether the cells on ventral myocardium exhibit intrinsic chiral biases.
SPECIFIC AIM 3: Determine cytoskeletal mechanisms in cardiac cell chirality during c-looping. We will
analyze the chirality of actin dynamics of cardiac cells, observe its change under drugs of interest, and confirm
the findings with ex ovo whole-embryo culture and genetic mouse models.
If the project is successful, we will be able to establish a set of novel high-throughput platforms for studying the
biophysics of asymmetric cardiac looping by measuring cell chirality, and further our understanding of
congenital heart disease. Also, this proposed research is transformative, and potentially open a new field of
research: cell chirality, a fundamental cellular property defining symmetry breaking in tissue development.

Public health relevance
Project Narrative The heart is left-right asymmetric with its apex pointing towards the left. Deviation from such an asymmetry leads to severe congenital malformations and has significant clinical implications. Here we propose to study the role of cell handedness in the establishment of left-right asymmetry during cardiac development.